Brain-wide functional mapping of circuits controlling hedonic feeding in obesity

7. Project Summary: The proposal describes a five-year plan for training Dr. Li Ye to achieve his goal to become an independent investigator in the central regulation of metabolism. The training and career development plan includes a compelling research project, training in laboratory techniques and didactic scientific and career development seminars and courses. The applicant has more than a decade of experiences working in both molecular metabolism and systems neurosciences. During his Ph.D., Dr. Ye was trained with Dr. Bruce Spiegelman, a well-recognized leader in the field of obesity and diabetes. His previous findings in metabolic research have been published in many high-impact journals and have been then cited near 4,000 times in the subsequent works of his peers. During the proposed training, Dr. Karl Deisseroth, a leading expert in neurosciences will mentor the applicant’s scientific and career development. Dr. Deisseroth has trained numerous prominent scientists who now hold faculty positions in academic institutions. In addition, an advisory committee with highly regarded expertise in hypothalamic and feeding research (Dr. Luis de Lecea and Dr. Brad Lowell) will provide the applicant scientific advice and career guidance. The overall goal of the project is to study neural mechanisms responsible for coordinating food intake and metabolic demands. The obesity epidemic is putting an enormous burden on the public health systems, by contributing to the increased prevalence of type 2 diabetes, cardiovascular and neurodegenerative diseases. Obesity is a result of energy imbalance, in which energy consumption chronically exceeds the expenditure. There are two types of feeding, one driven by metabolic need and the other by the hedonic aspect of palatable food. The former is mainly regulated by the hypothalamic and hindbrain structures that are responsive to peripheral hormonal signals such as leptin, insulin, and ghrelin. The latter is predominantly controlled by the reward systems including the mesolimbic pathway and dopamine signaling. Preliminary studies suggested these systems converge in the lateral hypothalamus area (LH). Dissecting the circuit, cellular and molecular bases separating these two systems in the LH is key to understanding the central control of energy balance and its dysfunction during obesity, however, differentiating intermingled neural ensembles within a brain region has been difficult. In his early postdoctoral work, the candidate has developed a series of CLARITY and optogenetics-based technologies with sufficient throughput to map brain-wide connectivity as well as with the ability to retain molecular information at the single cell level to distinguish intermingled neuronal populations. Using these tools, the candidate has successfully dissected two anatomically intermingled but functionally distinct ensembles representing opposite valences in the medial prefrontal cortex. These recent advances in systems neuroscience provide us a unique opportunity to dissect and differentiate the LH ensembles recruited by hedonic vs. metabolic feeding. The central hypothesis of this proposal is that hedonic and metabolic feeding recruit distinct ensembles in the LH. Specifically, these two ensembles quantitatively differ in: (1) the inputs they receive from upstream brain regions, (2) neuronal activity during different types of feeding, and (3) causal impact on feeding behaviors. Moreover, the adaptation of these ensembles to chronic high-fat diet is key to the development of hyperphagia. The general approach will be to use systems neuroscience tools to monitor and manipulate neuronal activity in behaving animals (Aim1 and Aim2). The molecular and structural adaption will be measured using ribosome-profiling and high-throughput imaging approaches (Aim3). Together, the proposal study will elucidate neural mechanisms underlying the HFD-induced hyperphagia; in the meantime, provide the candidate with the essential training to start an independent research program focusing on the central regulation of energy homeostasis. The Deisseroth laboratory and Stanford School of Medicine research community provide an ideal setting for training future independent investigators. This project will also bring together leading laboratories of the advisory committee that complement each other’s expertise. These outstanding resources will maximize the potential for the applicant to successfully transition to an independent investigator.

Public health relevance
8. Project Narrative The obesity epidemic is placing an unstainable burden on the population. Hedonic consumption of high-calorie food is a major drive for obesity in humans. However, brain systems that control hedonic and metabolic eating are heavily intermingled. We propose to use systems neuroscience approaches to dissect the neural circuits underlying hedonic eating, which will uncover novel mechanisms and potential targets for future therapeutics for obesity.